Plasma proteomic signatures of physical activity and Alzheimer's disease and related dementias

PROJECT SUMMARY/ABSTRACT
Physical activity (PA) has been listed as a promising intervention to delay or prevent Alzheimer’s
disease (AD) and related dementias (ADRD), however most studies used self-reported PA. Our preliminary
data show that, among older women, higher amounts of accelerometer-measured moderate to vigorous
intensity PA and steps/day are associated with lower risk of rigorously adjudicated incident mild cognitive
impairment (MCI) and ADRD. However, the molecular mechanisms through which PA influences ADRD risk
are unclear. The plasma proteome is a promising target for identifying the molecular mechanisms of PA
because proteins regulate biological processes, capture disease mechanisms, and may identify intervention
targets. Machine learning (ML) methods have been applied to derive PA proteomic signatures, proteomic aging
clocks, and ADRD proteomic clocks. However, few studies have systematically applied and compared ML
methods to derive PA proteomic signatures. The objective of this research is to enhance our understanding of
PA, proteomics, and how they relate to ADRD. I propose leveraging an NIA-funded study (RF1AG079149) that
will use the SOMAscan platform to measure ~7,000 clinically relevant plasma proteins and plasma AD
biomarkers in a case cohort of 2,836 (n=1,336 incident MCI/ADRD cases) women in the richly phenotyped and
racially/ethnically diverse Women’s Health Initiative (WHI) Memory Study (WHIMS) from samples collected in
1995-1998 (n=2,836) and 14-18 years later in 2012-2013 (n=1,000; 500 incident MCI/ADRD cases) and the
WHI Objective Physical Activity and Cardiovascular Health (OPACH; R01HL105065) study which collected
accelerometry in 2012-2014 among 6,489 women, including the 1,000 WHIMS women in RF1AG079149.
WHIMS contains longitudinal annual cognitive assessments and rigorously adjudicated MCI/dementia over 27
years of follow-up. In the R00 phase, I propose obtaining plasma biomarkers of AD pathology from 600 Black
and Hispanic/Latina OPACH women. Study results will be replicated in the Atherosclerosis Risk in
Communities study to extend findings to men and women. Our Aims are: (1a) Apply and compare ML methods
to derive PA proteomic signatures, (1b) Examine the overlap of PA proteomic signatures, proteomic aging
clocks, and ADRD proteomic clocks, (1c) Relate PA proteomic signatures with MCI/ADRD and cognitive
functioning, (2) Determine the role of PA-associated plasma proteins in our observed PA-MCI/ADRD
associations, and (3) Determine the associations of PA (self-reported and accelerometer-measured) and PA-
associated plasma proteins with plasma AD biomarkers among Black, Hispanic/Latina, and White women. This
research will advance understanding of the molecular mechanisms linking PA, aging, and ADRD. The addition
of plasma AD biomarker data to OPACH will have an enduring impact by enabling broader studies of
accelerometry and AD pathology in relation to aging-related phenotypes.

Public health relevance
PROJECT NARRATIVE This research will apply and compare machine-learning methods to derive plasma proteomic signatures of physical activity and examine them in relation to ADRD, yielding insight into the molecular mechanisms and biological processes through which physical activity may delay or prevent ADRD. This research may result in proteomic biomarkers of physical activity that measure the effect of physical activity to delay or prevent ADRD and suggest potential proteomic intervention targets.